CNS Exosomes-Mediated Adaptive Immunity in Alzheimer's Disease (AD)

Abstract
Alzheimer’s disease (AD) remains one of the most unmet medical challenges in our society. In the AD,
neuroinflammation has been increasingly recognized to play a central role in the pathogenesis of AD, in addition
to extracellular amyloid plaques and hyperphosphorylated tau based neurofibrillary tangles. Although the role of
innate immunity especially represented by microglia is well-established in AD, it is far less understood and
established about whether and how the T or B cell-mediated adaptive immunity is involved in AD pathogenesis.
In particular, whether there are brain- and AD-specific antigens to activate adaptive immunity and how these
antigens travel to peripheral remain to be investigated. Exosomes (size 40-100 nm), a major type of secreted
extracellular vesicles (EVs), are derived from intraluminal vesicles (ILV) that are budded inwardly from the early
endosomal compartment and are released from multiple vesicular bodies (MVB) during the maturation of
endosomes. EVs and exosomes secreted from various CNS cell types have emerged as a novel and important
intercellular pathway in the. Exosome-mediated secretion has also been implicated in initiation and propagation
in AD. Although exosomes secreted from various peripheral cell types especially immune and tumor cells trigger
immune responses, whether and how CNS-derived exosomes are immunogenic remains unexplored.
By employing cell-type specific ILV/exosome reporter (hCD63-GFPf/f) mice we recently generated, we
showed that astroglia-derived exosomes are associated with Aquaporin 4+ (Aqp4+) perivascular end feet/blood
vessel in the brain. hCD63-GFP+ astroglial exosomes can also be detected in blood serum of LPS-injected (but
not control) Glast-CreER+CD63-GFPf/+ mice. Excitingly, exosomes secreted from “reactive” astroglia (RAEs)
strongly activate CD4+ and CD8+ T cells in vitro and in vivo. Based on previous studies and our preliminary
results, we propose to investigate the following aims: 1) Determine pathological efflux of CNS cell-type specific
exosomes from brain and their entry into peripheral circulation in AD models; 2) Determine antigenicity of AD-
relevant astroglial exosomes in activating T cells in vitro and in vivo. We have generated a large amount of
preliminary data to support our rationales and to demonstrate feasibility for proposed aims. We will employ
mouse genetics, virus injections, immunohistochemical (IHC) analysis and in vivo two-photon imaging, primary
cultures, FACS, and biochemical approaches to investigate these two aims. Results from this project will
determine the efflux changes of neuron or astroglial exosomes from the brain and these exosomes’ entry into
peripheral circulation in AD models. In addition, our current study will investigate how T cells respond to “reactive”
astroglial exosomes. As reactive astroglia is commonly observed in neurodegenerative diseases including AD,
this will potentially unveil new mechanisms how T cells are involved in AD pathogenesis and help define specific
brain signals to activate T cells in AD, which subsequently facilitate the therapeutic development.

Public health relevance
Narrative Alzheimer’s disease (AD) remains one of the most unmet medical challenges in our society. This project will investigate whether there is a pathologically altered efflux of CNS cell-type specific exosomes from brain in AD models and whether and how these brain-derived exosomes may possess specific antigens to trigger peripheral T cell activation in vitro and in vivo. Results from this project will unveil new mechanisms how CNS and periphery interact in AD models.